IMSD at Stony Brook University: Maximizing Excellence in Research for Graduate Education

Project Summary / Abstract
IMSD at Stony Brook University: Maximizing Excellence in Research for Graduate
Education
The Stony Brook University Initiative for Maximizing Student Development: Maximizing
Excellence in Research for Graduate Education (IMSD MERGE) provides a comprehensive and
inclusive academic, research, and professional development training that will increase the
number of underrepresented (UR) biomedical science doctoral trainees advancing onto
academic and research career paths. This training program provides academic support and
professional development opportunities that are specific and customized to the needs of UR
trainees.
The goal of the IMSD MERGE training program will be carried out through three objectives:
1. Providing incoming UR doctoral students with the academic training and financial
support required to ensure that they reach parity in performance outcomes with their
well-represented (WR) peers in core courses, qualifying exams and navigation of first-
year laboratory rotations.
2. Providing rigorous, inclusive research training and mentoring to prepare trainees to
become ethical, independent scientists while fostering their self-efficacy and science
identity.
3. Providing trainees with opportunities to develop professional skills to prepare them to
secure independent funding and succeed as faculty and researchers at the highest
levels of the scientific workforce.
These aims will be accomplished through strategic activities carefully designed to support IMSD
MERGE trainees’ academic, research, and career success:
1) Funded research opportunities for a steady-state of ten doctoral students.
2) Academic preparation focused on metacognitive skill development and support in
gateway courses to ensure UR doctoral students achieve parity in grade
performance with their majority peers.
3) Promoting scientific engagement by fostering productive mentoring relationships
and opportunities through structured mentor training for trainees and their
research advisors.
4) Professional development training focused on the development of advanced
writing ability, preparing trainees for successful acquisition of research funding
and entry into the academic and research workforce.
IMSD MERGE collaborates with biomedical science faculty from eight graduate programs at
Stony Brook, addressing critical issues impeding training and career success for UR scientists.
Project leadership will identify key junctures in academic development and design interventions
and support efforts to improve underrepresented doctoral students’ persistence and
performance outcomes. Stony Brook is strongly committed to the objectives of IMSD MERGE,
with various units committing additional funding support to expand the population of
underrepresented Stony Brook doctoral students benefiting from the activities implemented for
this training program.

Public health relevance
Project Narrative IMSD at Stony Brook University: Maximizing Excellence in Research for Graduate Education This proposal aims to create a diverse group of highly motivated, exceptionally trained interdisciplinary scholars prepared to pursue research careers in the biomedical sciences. The training program focuses on efforts that build a strong, shared scientific identity amongst underrepresented biomedical science scholars across multiple degree programs, building their confidence and motivation to pursue research careers. These trainees will make novel contributions to the body of scientific knowledge that will lead to discoveries to improve our nation’s health.